American Physician Scientists Association Annual Meeting

APSA ANNUAL MEETING PROJECT SUMMARY
Due to their unique training in both biomedical research and clinical medicine, physician-scientists serve an
important role in dissecting the pathophysiology of human disease to develop new treatment modalities for
patient care, which is integral to the continued success of the scientific enterprise. Physician-scientists also
provide a critical pipeline for faculty and leaders in academic medicine. In June 2014, the National Institutes of
Health (NIH) Physician-Scientist Workforce (PSW) Working Group released a report detailing the present state
and projected future of the PSW. In addition to the overall small number of physicians pursuing research
(1.5%), the constituency of the workforce is aging (average age at first R01 is 44 for MD-PhDs), lacking in
underrepresented minority (URM) representation, and is being fed by a lengthening pipeline. Therefore, it is
increasingly important to recruit and support trainees who are not only competitive, but resilient and diverse.
The American Physician Scientists Association (APSA) and the APSA Annual Meeting (AM) were created to
foster and strengthen the national community of physician-scientist trainees, as no pre-existing venue
encompassed all members of this trainee community. Organized in conjunction with the annual meetings of the
Association of American Physicians (AAP) and the American Society of Clinical Investigation (ASCI), the APSA
AM is truly unique in that it unites physician-scientists at all phases of the career spectrum, from aspiring
undergraduates, to current trainees, residents, and fellows. Since its inception in 2005, the APSA AM has
grown in services provided and total participants, boasting an average of 350 participants over the past four
years. The conference provides a structured environment to disseminate career advice from established
physician-scientists in all career sectors, to promote the development of mentoring relationships, and to
foster community building amongst physician-scientist trainees. Moreover, the APSA Annual Meeting provides
a critical venue at which issues faced by trainees, including those from under-represented groups, can be
discussed and addressed with senior physician-scientist leaders. This application seeks funds to specifically
enhance the diversity of APSA Annual Meeting attendees by providing travel awards for individuals from racial
and ethnic groups that are underrepresented in health-related sciences, individuals with disabilities, and
undergraduate students from disadvantaged backgrounds, and supporting costs associated with hosting
speakers and panelists that address issues of diversity.

Public health relevance
APSA ANNUAL MEETING PROJECT NARRATIVE Despite the importance of physician-scientists as critical components of the medical research enterprise and the NIH initiatives put in place to preserve this rarified group, the decline of physician-scientists in the United States remains a major concern. The APSA Annual Meeting directly supports the future of physician-scientists in the United States by providing current trainees with an unparalleled perspective on the career opportunities available to them and by providing numerous opportunities for vertical and horizontal mentorship. This application specifically seeks funds to enhance diversity at this meeting.